Bioanalytical Core

The University of Louisville Hepatobiology and Toxicology COBRE is a multidisciplinary group of investigators
focusing on the liver and liver injury, gut:liver interactions, and liver:environment/toxicant/drug interactions.
The Bioanalytical Core (Core C) is an integral part of the COBRE and will continue to play a key role in the
implementation and future development of COBRE-funded projects. The Core provides the necessary
expertise and state-of-the-art equipment for rigorous and comprehensive experimental evaluation of cell and
tissue specimens to investigate the pathogenic mechanisms of liver disease. Besides providing requisite
analytical services, a major goal of the Core C is to promote the education and training of the Center members,
with particular attention to the COBRE junior investigators. Core C will specifically communicate with COBRE
junior investigators regarding their experimental requirements on a continual basis and appropriately
participate in the planning, execution and data interpretation. Core C will also interact with other COBRE Cores
on a regular basis in order to avoid duplication of equipment or instrumentation and foster innovative protocol
development and refinement, exchange of ideas, and integrative analysis of data. In addition to the upgraded
existing equipment (BD FACSCanto II, Cellomics and Seahorse analyzers) Core C will also provide technical
and analytical expertise with newly acquired, state-of-the-art, centralized equipment that includes BZ-X810
automated imaging microscope (Keyence), QuickPlex SQ 120 multiplex MSD analyzer and QuantStudio 6 Flex
Real-Time PCR System.
The Core facility is located in Clinical and Translational Research Building with 2,500 sq.ft of operating
space that is contiguous with the 20,000 sq.ft. laboratory space of the Hepatobiology and Toxicology COBRE.
Dr. Barve (Director) and the Core C research team have extensive experience in the development and
execution of molecular, biochemical and immunological analyses that are critical for the operational and
functional aspects of Core C. Dr. Barve was/is an investigator (PI, Co-PI or Co-I) on several NIH-funded
grants, served for nearly a decade as the Director of the Molecular and Cytokine Core Laboratory of the NIH-
funded GCRC, and supported the career development of several junior faculty. To remain a vital integrative
component of the Center that provides services, not only for members but also the Institution as a whole, the
Core C has the following specific aims: 1) To foster the development, sustainability and success of the
proposed COBRE projects and pilots; 2) To play an active and significant role in the education and training of
the investigators; 3) To assist and participate in the development of new experimental protocols; and
techniques and 4) To become an integral and self-sustaining component of the COBRE Center.